Using Immersive Virtual Reality and Media Literacy to Enhance Adolescents' Coping Skills in the Face of Traumatic Online Experiences

PROJECT SUMMARY
Race-related traumatic online experiences have become daily stressors in the lives of adolescents of color.
Black adolescents for example, have an average of 5.2 incidents of racial discrimination per day, with those
occurring online as most frequent. Examples include witnessing calls for genocide of people of color, mock
lynchings, and having your intelligence questioned because of your race. Media literacy education and school-
based mental health interventions, where one might expect adolescents to receive preparation for these
experiences, are either inadequately preparing youth, or exclude a discussion of the issues altogether. Media
literacy programs, for example, only cover race through a cursory lens. Other school-based efforts, such as
mental health interventions, may be stigmatized or stigmatizing, limiting their effectiveness. There is a dire
need for training in how to critique and cope with race-related messages in a safe, and engaging environment,
free of stigma. We propose an unusually innovative and immersive virtual reality (VR) media literacy and
coping skills prevention intervention. Drawing on media literacy as health promotion framework, best practices
in immersive VR for psychoeducation, and culturally-responsive computing theory, we will design and develop
the intervention, and evaluate its efficacy with a pilot randomized controlled trial. The potential impact is far
reaching, including curbing the alarming, rising rates of depression, anxiety, and other mental health symptoms
among Black and Latinx communities since the beginning of the COVID-19 pandemic. The project is perfectly
aligned with the Transformative Research Award, in that findings have the potential to fundamentally reshape
how we educate young people to critique, counter, and cope with online experiences. Given that virtuality is
believed to be the wave of the future, with some arguing for a coming “metaverse,” where much of our lives will
be through VR, this project will provide a model for ensuring that psychoeducation, delivered by an immersive
VR intervention, can meet the unique needs of adolescents of color. In addition, we hope to usher in a world
where every internet user is educated about the mental health impacts of online social interactions and
experiences, as they receive expanded access. At the conclusion of this project, we will produce an immersive
VR intervention that has the potential to reduce disparities in access to mental health services in underserved
communities, leading to better mental health equity and outcomes among Black and Latinx adolescents. This
transformative experience will help Black and Latinx young people become more efficacious with respect to
racial coping. It will also provide a toolkit for students to imagine and create a digital world where they are able
to thrive in the face of traumatic online experiences.

Public health relevance
PROJECT NARRATIVE Race-related traumatic online experiences have become daily stressors in the lives of adolescents of color, yet media literacy programs fail to help young people manage these challenges. We propose to address this need with the design, development, and evaluation of an immersive virtual reality (VR), media literacy, and coping skills intervention. Guided by a media literacy as health promotion and prevention framework and culturally responsive computing theory, the VR intervention will build on Black and Latinx adolescents’ strengths and provide immersive practice to enhance the learning of coping skills and racial coping self-efficacy for dealing with negative race-related digital media.